Integrated Technologies

Abstract - Integrated Technologies Core
The overall goal of the Integrated Technologies Core (ITC) is to provide coordinated access and cost-effective
support for our facility – the Center for Biomolecular Structure (CBMS).
The first role of the ITC within the CBMS is to enable technical and engineering support for two of the three
scientific technical cores; these two cores are the ones that depend on hard-x-ray diffraction, two
Macromolecular Crystallography (MX) beamlines: Frontier Microfocus Macromolecular Crystallography
(FMX), and Highly Automated Macromolecular Crystallography (AMX), and scattering: Life Science X-ray
Scattering (LiX), in structural biological studies. Constructed predominantly with an award from the
National Institutes of Health (NIH), these three beamlines support structural biology and other disciplines,
and the funding in this grant will support their continued operation. The third technical core, the Imaging
core, serves five beamlines built and operated mostly by the Department of Energy (DOE) Basic Energy
Sciences (BES), for which the life-science studies that we will support on these beamlines represent a minor
component of their entire programs. Therefore, the maintenance and upgrade role that the ITC plays for the
MX and Scattering Cores will be played by existing BES-sponsored technical staff for the Bioimaging Core.
The second function of the ITC is to coordinate standards for hardware, software, controls, and networking
and computing systems. It also assures resource sharing among all scientific technical cores in CBMS and
supports efficient communication with the National Synchrotron Light Source II (NSLS-II) beamlines and
the technical and engineering groups.
We believe that by organizing our technical staff to function across the three beamlines we will make better
use of our resources. We estimate that our collaboration saves personnel resources equivalent to two to three
FTE. By pooling spare parts, and assuming equipment failures to be random, for three beamlines the
reduction in investment in spares amounts to approximately 40%. This will allow us to provide backup
coverage and extra support among the three, to be consistent in instrument design, and to make efficient
use of accepted facilities-maintenance standards. Numerous resources within the ITC exist also in the rest
of the NSLS-II; for us to share and exchange knowledge and apparatus will cross-fertilize opportunities for
all of us and foster greater efficiency.